Administrative Core

PROJECT ABSTRACT
The P01 Administrative Core provides leadership and administrative support for all of the P01
activities. The Administrative Core will be responsible for overseeing the interactions among the
individual projects, integrating their activities and managing communication.